Core C: Community Engagement Core

PROJECT SUMMARY/ABSTRACT – COMMUNITY ENGAGEMENT CORE
N-Nitrosamines are a family of chemicals that include some of the most potent mutagens known. N-
nitrosamines are a major concern for people who live near the Olin Chemical Superfund Site, because
there is a plume of N- nitrosodimethylamine (NDMA) contamination of water and soil that stretches
nearly a mile underground, contaminating municipal and private wells. NDMA is also a concern of the
Passamaquoddy Tribe, because the methods used for water treatment are known to lead to formation of
NDMA. Over many years, the MIT team has created strong relationships based on trust and mutually
shared goals, and these relationships are the basis for ongoing and proposed work. Via
bi-directional communication and collaboration with stakeholders, the CEC plays a vital role in
accomplishing its mission of educating youth in environmental health sciences, inspiring research
careers for the next generation of scientists, and reducing the amount of N- nitrosamines in
drinking water. Speciﬁc Aim 1 is to teach. Working with BMR Projects 1 and 2, the CEC will create
innovative, hands-on learning experiences that teach key concepts of biology and environmental
health sciences. Working with the tribal educators, the MIT team will co-create and distribute
hands-on experiential learning kits to teach key concepts of biology and environmental health to
Tribal Youth. The CEC will also work with high- school teachers in Wilmington to optimize hands-on
teaching experiences for Wilmington high-school teachers to share knowledge related to the research
focus of the MIT SRP Projects 1 and 2. Using tactile teaching kits, the MIT SRP will address the
pipeline problem by co-creating and oﬀering teaching individuals to inspire careers in
environmental health. Speciﬁc Aim 2 is to intervene and prevent disease by working with all
Projects to empower stakeholders to reduce the levels and toxicity of hazardous substances. The CEC
will partner with community stakeholders to better communicate with organizations that can help to
provide cleaner water, including the EPA. In addition, to reduce the levels of toxicants, the CEC
(with support from the Environmental Science and Engineering [ESE] Projects 3 and 4), will team up
with a non-proﬁt organization that teaches tomorrow’s leaders in industrial chemistry to adopt
strategies that reduce and prevent environmental contamination. Speciﬁc Aim 3 is to support the use
technology that will be developed by ESE Projects 3 and 4 to perform Citizen Science and provide ﬁltration devices to the community. Data on the identity and the levels of N-
nitrosamines
will be collected by the CEC in collaboration with community members via a Citizen Science project.
Data on the levels of N-nitrosamines will be integrated with data from the other Projects and Cores
to contribute to risk evaluation. The CEC will also help to deploy a novel ﬁltration device that
destroys N- nitrosamines. By empowering people with knowledge of what is in their water and by
oﬀering ﬁltration devices, the CEC will reduce the amount and toxicity of hazardous chemicals in drinking water.

Public health relevance
PROJECT NARRATIVE – COMMUNITY ENGAGEMENT CORE The mission of the MIT Superfund Research Program (SRP) Community Engagement Core (CEC) is to continue to strengthen robust bidirectional communication and collaborations with stakeholders that will make it possible to be responsive to the needs of community members by reducing the amount and toxicity of hazardous chemicals in the environment. The CEC will use tactile learning kits (invented by the CEC leader) to teach community members about how environmental chemicals can cause cancer and will work with educators to inspire students to pursue research careers in environmental health. Working with the EPA, community members, and other MIT SRP members, the CEC will do Citizen Science research to reveal the amount of contamination in water and will provide ﬁlters that will reduce the amount of hazardous chemicals in drinking water.